Genomic Instability and Cancer Genetics

GENOMIC INSTABILITY AND CANCER GENETICS PROGRAM
PROJECT SUMMARY/ABSTRACT
The overall goals of the Genomic Instability and Cancer Genetics (GICG) Program are to determine the
mechanisms by which genome stability is maintained to prevent tumorigenesis, to define the landscapes of
cancer genomes, and to expose the therapeutic vulnerability of cancer due to genomic alterations. The GICG
Program is organized around three themes: 1) fundamental mechanisms of genome maintenance in DNA repair,
replication fidelity, and cell cycle control; 2) modifying and regulatory factors of tumorigenesis; and 3) genomic
alterations in cancer.
The GICG Program is composed of a highly qualified and collaborative team of 40 Members with diverse and
complementary expertise from 21 departments, nine schools, three universities, and one institute. Our research
is currently supported by $10.8 million in cancer-relevant funding ($4.6 million annual direct funds from NCI), 32
cancer-focused NIH R01 or equivalent research grants to 21 independent PD/PIs and 14 multi-PI awards
including one P01 award. Productivity and collaboration within GICG are evident from the 523 cancer-focused
publications during 11/2017-10/2022 (compared to 483 during 11/2012-10/2017), 33% being collaborative
publications including 11% intra- and 28% interprogrammatic, 63% multi-institutional collaborative publications,
and 38% of the publications are in journals with impact factor (IF) of 10 or greater.
Examples of impactful science during the current grant period are exemplified by the application of an innovative
single-cell based CRISPR screen of ~450 DNA repair genes to decipher the in-depth mechanisms of DNA repair;
the demonstration of critical roles of BRCA1-PALB2-BRCA2 interactions and associated factors in replication
fidelity, cell cycle checkpoint control and tumor suppression; the identification of a new mechanism of mitotic
spindle assembly; the discovery of novel functions of TP53 and its regulated genes in a diverse array of activities
that modulate tumor development; identification of new pathways in cell fate determination after DNA damage;
new findings on the relationship between tissue homeostasis and tumorigenesis; identification of distinct
subgroups of neuroendocrine tumors, and identification and validation of fibroblast growth factor receptor 2
(FGFR2) mutant targetable drivers; and the development of numerous genomic tools for precision oncology.
Examples of outstanding programmatic accomplishments and impact include the forward and reverse translation
of the mechanistic and genomic studies, the catchment relevance of GICG research to a broad range of cancer
types as well as key cancer risk factors, the Program participation in community outreach activities, training of
scientists from under-represented groups, and the highly collaborative and synergistic team science as reflected
by multi-PI awards and a new P01 program project grant.

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)